Spatiotemporal checkpoints of macrophages in aortic aneurysms- Renewal

Summary
Abdominal Aortic Aneurysm (AAA) is an aggressive vascular disease that carries a significant human death toll.
The inflammatory AAA microenvironment mainly driven by aortic macrophages (MØ) enables AAA progression
by promoting extracellular matrix (ECM) degradation leading to a progressive dilatation of the aortic wall which
will eventually rupture and cause death. While our findings in the previous funding cycle have elaborated on the
effector roles of MØ within the AAA mayhem, the upstream mechanisms derived from the expanding AAA that
subsequently induce MØ reprograming remain poorly defined. Our rationale is based on compelling new
preliminary results using single-cell RNA sequencing and functional studies of human and mice AAA that
demonstrate that the homo-dimeric activation of cadherin11 (Cdh11) with itself amplifies aortic MØ inflammatory
functions by promoting the discharge of proteolytic factors in the AAA sac. The activation of Cdh11 expressed
by fibroblasts triggers the expression of Csf1 via YapTaz/Tead1 that acts on MØ via its receptor Csf1r. We show
that inhibition of Cdh11 with a novel small molecule inhibitor prevents mice from developing AAA by tempering
the MØ inflammatory and proteolytic responses ensuing the inhibition of ECM degradation. We observed that
Cdh11 controls the level of membrane-bound and secreted variants of Csf1 (mCsf1, sCsf1) which could
supervise the intensity of MØ inflammatory responses at distinct sites within the AAA sac. We postulate that
within the expanding AAA sac, local endotensions activate fibroblast-Cdh11 thereon fostering the local secretion
of Csf1 and its variants through YapTaz/Tead1 dependent pathways. This fuels the amplification of deleterious
MØ responsescreatingacontinuumthatsustainsECMdegradationandpromoteAAAdevelopmentandrupture.
We will concert with experts in the fields of Cdh11 and Csf1 to address our hypothesis in 3 specific aims. In aim
1, we will delineate the impact of conditionally deleting Csf1 in Cdh11 fibroblasts in AAA and study the effects
on MØ phenotype and activation. Transcriptome and epitope mapping will provide new mechanistic insights
imposed by Cdh11 in AAA. In aim 2, we will define whether Cdh11 inhibition can regulate MØ proliferation,
clonality and plasticity in AAA by using sophisticated MØ conditional mice (Confetti, Fucci). In aim 3, we will
interrogate the mechanisms underlying the mechanical activation of Cdh11 and test the role of YapTaz/Tead1
in regulating Csf1 and its variants in in vitro approaches. The distinct role of mCsf1 and sCsf1 and their impact
on MØ activation will be directly tested in AAA using transgenic mice overexpressing these isoforms. Spatial
transcriptomic analysis of human AAA will elucidate the cartography of Cdh11/MØ interactions and their impact
on neighboring cell clusters in AAA. This proposed research is provocative and innovative as the role of Cdh11
in AAA is undefined. The use of clinical samples will provide solid pathways relevant to clinical AAA pathology.
The completion of this study will yield new insights into unexplored inflammatory pathways that drive AAA and
test the efficacy of reversing these pathological traits, urgently needed to curb AAA.

Public health relevance
Project Narrative Abdominal Aortic Aneurysm (AAA) carries an enormous human toll and is characterized by macrophage- overactivation that causes profound degradation of the aortic matrix accelerating rupture and mortality. We observed that within the AAA microenvironment, increased local tension activates Cdh11 which exerts strategic control of aortic macrophage reprograming capable of collapsing the aortic tissue. Our experiments will detail mechanisms connecting Cdh11 and pathologic macrophage function in AAA by using mice models of macrophage proliferation, lineage, plasticity and newly designed drug targeting Cdh11 coupled with state-of-the- art sequencing approaches in human samples to thoroughly delve into new treatment approaches urgently needed to treat individuals with AAA.